Creating Protective Environments through School Policy Development

ABSTRACT
Research is needed to evaluate and inform school policy to prevent multiple forms of youth violence. The present study
seeks to comprehensively evaluate existing school policy to address sexual violence and harassment, and other related
forms of violence among youth, as well as facilitate school and community agency partnerships to enhance strategies for
sexual violence prevention. In Phase 1, the team will build capacity for the project through a process of finalizing the
research strategy and gathering baseline data from a variety of sources. The formative process will be conducted in a
collaborative, community-engaged approach, with the support of a Research Advisory Board and local stakeholders.
School policies from 6 representative schools will be collected and systematically analyzed in tandem along with
multiple sources of publically available and school provided data. Interviews will be conducted with school
administrators, and a series of focus groups will be conducted with students and school staff to assess perceptions of
policy implementation. In Phase 2, the research team(s) will collaborate to implement a pilot study of the policy
development and technical assistance intervention. This intervention is currently implemented in the RPE work plan in
the MY Consent Culture program by RPE-fundee, MOASH, but will be further developed through the formative process.
MOASH will partner to develop strategies to provide participating schools with technical assistance to enhance existing
school district policies in accordance with best practices. A delayed treatment, mixed methodology design will be
utilized to evaluate the efficacy of technical assistance provided to 6 high schools in the pilot study. Technical assistance
will be provided by MOASH and other community partners, designed to provide hands-on support in refining and
implementing school policy to prevent and respond to sexual violence, teen dating violence, and bullying among
students. Half of schools will participate in technical assistance in Year 2 and the remaining half in Year 3. An innovative
survey design will be utilized to examine longitudinal outcomes over time. Specifically, assessments of incidence of
violence, attitudes towards violence, school climate, and school connectedness will be conducted. These date will be
collected from both the MiPHY State-administered online survey and project surveys in schools. Two cohorts of youth in
the 7th and 11th grade will be recruited for participation in each year of the study, in alignment with MiPHY
administration schedules. Surveys will be administered one time per year for a total of five time points. We will test a
conceptual model that posits a causal relationship in which technical assistance around policy refinement and
implementation increases coordination of services with community organizations, improves school connectedness,
decreases attitudes endorsing violence, and subsequently decreases sexual violence and harassment, teen dating
violence, and bullying victimization and perpetration. In Phase 3, a full-scale rigorous evaluation will be conducted,
following the same methods, with a sample of 40 schools representing the five geographic regions of the state. If
effective, findings from the present research will provide a robust foundation to inform the widespread dissemination of
this promising approach to strengthening school violence policy and primary prevention efforts to address multiple and
co-occurring forms of violence among youth.

Public health relevance
PROJECT NARRATIVE The proposed research will evaluate existing school policy to prevent and respond to youth violence. Technical assistance will be provided to inform and improve policy implementation based on best practices. The proposed delayed treatment – mixed methods design is theoretically driven and incorporates a scientific research design to address the effect of policy on school climate, prevalence and incidence of physical sexual violence and harassment, bullying, and teen dating violence among adolescent males and females of diverse races/ethnicities and social classes. Examination of process, efficacy, and policy outcomes within the context of historical trends in violence and policy, will provide a foundation to inform continued research and practice for widespread dissemination of this promising approach to policy and prevention for youth violence.